Manipulation of Immuity to Treat Uveitis

The goal of this proposal is to further understand how the neuropeptide alpha-melanocyte stimulating hormone
(α-MSH) regulates immunity, and how it can be used to suppress uveitis to reestablish immune privilege.
Previously published work, and the progress of our past grant-period demonstrated that α-MSH-treatment
during uveitis can restore immunosuppressive activity of retinal pigment epithelial cells (RPE). In addition, we
have demonstrated that part of immune privilege is suppression of the phagocytic/antigen-processing pathway
within macrophages by healthy RPE. This suppression is mediated by α-MSH produced by RPE and is
dependent on expression of the α-MSH-receptor, melanocortin 5 receptor (MC5r), in the retina. Therefore,
suppression of EAU, and the induction of regulatory T cells by α-MSH-therapy is possibly associated with
regulating antigen presenting cell activity within the uveitic eye. This would be mediated through α-MSH
binding specific melanocortin-receptors on the RPE and APC of the retina. Therefore, we hypothesize that α-
MSH regulates the processing and presentation of antigen within the immune privileged microenvironment,
and that α-MSH-therapy acts through this mechanism to suppress autoimmune uveitis. We will demonstrate
this regulation by assessing the role of α-MSH to regulate the phagocytic pathway in macrophages and
microglial cells; by determining the ability of α-MSH-treated APC to antigen-activate effector T cells; and
assess the potential for α-MSH to mediate innate-immune memory tolerance in macrophages. The α-MSH-
therapy will involve treating EAU with whole neuropeptide and specific melanocortin-receptor-agonists. The
regulation of antigen uptake, processing, and presentation will be assayed on both tissue macrophages, and
retinal microglial cells. Also, we will examine retinal microglial cells and α-MSH-treated macrophages for
expression of markers and activity associated with innate-immune memory tolerance. We will examine
changes in this regulation in the initial stages of EAU as suggested by our preliminary data. Our proposed work
will have a meaningful impact, because the results will provide new information about the molecular
mechanisms of uveitis, and α-MSH anti-inflammatory-activity. Also, it will define how melanocortin-based
therapy can regulate antigen presentation and T cell activation by suppressing the central drivers of
autoimmune disease.

Public health relevance
Uveitis is the third leading cause of vision loss the US, and it affects many during their most productive working years. The standard approach for treatment has not changed in almost 60 years. It is our objective to find a way of using the very molecules that regulate inflammation within the healthy eye that stops uveitis, that is well tolerated, and that it will provide a long-term benefit to preserve vision.